Translational Technologies Core

Translational Technologies Core
PROJECT SUMMARY/ABSTRACT
The Translational Technologies Core will support and provide expertise related to genetics and neuroimaging
throughout the Center. It is well known that genetic factors are important in modulating risk of alcohol use disorder
(AUD) and related traits. Genomewide association studies (GWAS) have identified multiple genetic risk loci for
AUD, for problematic alcohol use, and for quantity-frequency measures such as AUDIT-C and drinks per week.
Major function of the Genetics component will be to support microarray genotyping for each of the projects
(including pilot projects) involving human subjects, for the purpose of identifying genotype/phenotype
associations based on polygenic risk scores (PRS) of AUD and related traits. The Illumina Global Diversity Array
(GDA) – also used by the “All of Us” research project, and with good coverage of all major US population groups
and pharmacogenomic content, will be genotyped on all CTNA subjects. Most GWAS have focused on
European-ancestry populations; we will also use the best available methodology to study non-European
populations in a PRS context. Genetics component investigators will advise Center investigators on issues
related to genetics studies. We will also bring to bear a rich dataset of GWASed subjects with alcohol and other
substance dependencies that can be used to test hypothesis related to Center findings and goals; and we will
continue pilot work in related topics of interest, e.g., epigenetics and transcriptomics of alcohol dependence. In
turn, the Neuroimaging and Computational Neuroscience Component of the TTC will serve two key support
goals across the Center: i) Neuroinformatics Acquisition and Harmonization Support: Building on the prior
iteration of the Center, the TTC will provide a robust and centralized database for multi-modal neuroimaging,
processing, integration and analytics. Specifically, all CTNA imaging data collection will be harmonized with the
standardized imaging protocols developed by the Human Connectome Project (HCP). This will enable
acquisition and analysis at dramatically enhanced spatial and temporal resolution across the entire Center,
building programmatically on deep investments by the imaging community in these state-of-the-art data
collection tools. Moreover, the TTC will feature an integration between the field-wide accepted XNAT (eXtensible
Neuroimaging Archive Toolkit) database standard and the novel Yale-developed Quantitative Neuroimaging
Environment & ToolboX (Qu|Nex) – a cutting-edge ‘turnkey’ container neuroimaging system built collaboratively
with the HCP team. Notably, the. XNAT-Qu|Nex integration serves the framework for the ‘Connectome
Coordinating Facility’, which we propose to deploy here for the entire Center. ii) Computational Neuroscience
Support: The TTC will provide analytic support for the computational modeling and integration of innovative
techniques for neuroimaging analysis using whole brain high-resolution transcriptomic data obtained from the
Allen Human Brain Atlas. Collectively, the TTC will serve as a central state-of-the-art integrated informatics
database and computational analytic resource for CTNA projects involving genetics and neuroimaging.